Laboratory Animal & Comparative Medicine Training

Project Summary
The need for veterinarians trained as biomedical scientists is well-documented. We request here continued
funding to support four post-DVM fellows per year for three years of research training. Optimal research
training exists when qualified and motivated trainees work in the laboratories of experienced, productive and
well-funded scientist mentors. Such mentors impart the knowledge, work habits, communicative skills and
research skills enabling trainees to succeed as independent scientists and contributors to multidisciplinary
research teams. These scientists will be skilled both in the use of animal models and the application of cellular,
immunologic, molecular, genomic or translational approaches to address questions of human health
significance. Promising trainees identified through a summer fellowship program and multiple other strategies
are encouraged to apply to this program. Diversity is sought through a multi-level outreach program. Trainees
typically enroll in the Graduate School of Wake Forest University and pursue a PhD degree in one of the 7
biomedical tracks offered at Wake Forest School of Medicine. Trainees will choose a Mentor from among a
group of well-funded and experienced scientists and educators and will be assigned an Associate Mentor with
expertise relevant to the trainee's research project. Associate Mentors are faculty members without
independent research funding and/or with limited training experience, but with critical clinical or core laboratory
expertise. This co-mentoring approach will allow Associate Mentors to gain training experience in a team
setting. There are 19 Mentors with independent research programs and funding, and an additional 6 Associate
Mentors. Of the training faculty, 9 are DVMs (including 5 DVM/PhD or DVM/MS researchers), 18 are PhDs,
and 4 are MDs (including 3 MD/PhDs). In addition to mentored research and required coursework, all trainees
will attend weekly research seminars and journal clubs. Training in the responsible conduct of research is
integral and includes mentoring, didactic sessions, and group discussion. Structured evaluations of both the
trainees and the program are conducted annually. There are 6 areas of research emphasis, based on interest
in training and networks of collaboration among productive, funded investigative groups: 1) cardiovascular
disease/diabetes, 2) cancer biology, 3) women's health and reproductive medicine 4) microbiology and
immunology, and 5) radiation injury, and 6) regenerative medicine. Unique features of the research
environment include access to national primate resources; a world-class program in tissue engineering at The
Wake Forest Institute of Regenerative Medicine; the Wake Forest Translational Science Institute; and our long-
standing collaborative veterinary training programs in Indonesia. In the past 15 years, 14 fellows have
completed research training through this program, and 12 remain in academic, industry or government
biomedical research. Nine sought and were awarded PhDs. Three fellows will defend in 2018. Seventy-six
scientific publications have resulted from T32-supported projects in the past 10 years.

Public health relevance
Project Narrative This application seeks continued support for a long-standing mentored research training program for veterinarians. The program focuses on 1) cardiovascular disease/diabetes, 2) cancer biology, 3) women's health and reproductive medicine 4) microbiology and immunology, 5) radiation injury, and 6) regenerative medicine. Training typically leads to a PhD degree and provides the ability to conduct independent, investigator-initiated research.